Mobilization and trafficking of central ILC progenitors

PROJECT SUMMARY
ILCs play essential roles in peripheral tissues by regulating tissue homeostasis, immunity and inflammation.
Peripheral ILC populations undergo spontaneous and induced attrition over time and should be replenished to
maintain their normal numbers and subset composition. The first step to deliver ILC progenitors into peripheral
tissues is the mobilization of ILC progenitors from the central hematopoietic tissue, bone marrow (BM), and this
presumably requires regulated emigration of ILC progenitors from the BM and their ultimate trafficking into
various peripheral tissues. Unfortunately, we hardly understand how various ILC progenitors are
mobilized from the BM and characteristically distributed to various peripheral tissues in steady state
and how these processes are altered in inflammatory conditions. The overarching objective of this
project is to understand the mobilization and trafficking of BM ILC progenitors.
Several key questions arise in terms of the mobilization and migration of central ILC progenitors: Which
progenitors dominantly emigrate from BM to generate peripheral ILC subsets in steady state? Are they multi-
potential and/or committed progenitors? What are the mechanisms and signals that trigger their emigration?
How do these progenitor cells in the blood circulation enter distinct peripheral tissues? Is the migration
mechanism universal or specific for each progenitor subset or tissue site? How do inflammatory signals alter
the mobilization and migration patterns of ILC progenitors, and can we control tissue ILC activity in pathogenic
conditions by utilizing mobilized BM ILC progenitors or targeting their mobilization and migration?
We devised the following specific aims to investigate these questions regarding the mobilization and
trafficking of ILC progenitors. Aim 1. Identify the mechanism that mobilizes central ILC progenitors in
steady state; Aim 2. Identify the mechanism by which central ILC progenitors are mobilized in
inflammatory conditions; Aim 3. Identify potentially diverse mechanisms for the entrance of mobilized
ILC progenitors into distinct peripheral tissues. The project will generate fundamental knowledge on how
the peripheral ILC system is maintained and regulated by the mobilization and potentially selective trafficking of
ILC progenitors into peripheral tissues. The outcomes will greatly enhance our understanding of the
maintenance and regulation of peripheral ILCs and will provide novel insights into therapeutic
utilization and control of ILC progenitors.

Public health relevance
PROJECT NARRATIVE The project is to understand the fundamental aspect of the origin, trafficking and destination of the progenitors for specialized early-acting lymphocytes called innate lymphoid cells. The outcomes will greatly enhance our understanding of how these cells in key peripheral tissues are established and maintained to ward off pathogens and regulate inflammatory and allergic responses. Moreover, the results are expected to provide novel strategies to harness and control these important immune cells.